UCSF - UCB TRAC Basic Science CORE

PROJECT SUMMARY - BASIC SCIENCE CORE
To combat the tuberculosis (TB) epidemic effectively, we need to reinvigorate TB basic science research with
an infusion of new investigators, novel perspectives, and cutting-edge innovations. The goal of the Basic Science
Core of the UCSF-UCB TRAC is to address the need to accelerate innovative, multidisciplinary research in
tuberculosis research that spans the spectrum of disciplines from basic to clinical research. We expect to
catalyze innovation and multidisciplinary work in TB research by: (1) Promoting New Investigators (NIs) in their
TB research career by providing specific mentorship and training, and (2) Lowering the barriers to entry for New
Investigators and non-TB researchers to bring innovative ideas and technologies to TB research through a set
of innovative pilot awards. By providing access to expertise in planning TB experiments and the relevant, trained
manpower to execute the experiments, we will have removed probably the biggest barrier for NIs to engage in
TB-relevant research. The Basic Science Core expects to have radical benefits in accelerating fundamental
discoveries in TB research and provides a fit-for-purpose model of resource access, mentorship and training
designed specifically to address the needs of TB basic scientists.